Accurate, fast, and distributed atlas-scale integration of scRNAseq data

Project Summary
Single-cell transcriptomics have revolutionized biomedical research over the last decade and are now widely
used in both industry and academia. Today there are >100 million cells profiled and available in the public
domain, and many of these datasets were generated through Common Fund projects such as HuBMAP, GTEx,
BRAIN, and SCORCH. These and other projects aim to serve as reference datasets that can be re-used for
comparisons with other datasets, and such resources are often referred to as cell atlases. Therefore, the ability
to integrate cell atlases with each other and with external datasets is crucial to ensure their utility. However,
combining datasets can be challenging due to the presence of batch effects—experimental artifacts resulting
from variability in sample processing. If not accounted for, batch effects can be mistaken for biological signals.
In recent years, several computational methods to identify and correct batch effects have been developed.
Nonetheless, challenges remain, particularly in scaling up to millions of cells from thousands of batches.
Additionally, users need to download large volumes of data, which can be costly and time-consuming.
One of the most popular methods for batch correction is Harmony, which we published in 2019. Harmony is
transparent, intuitive, fast, and accurate, as demonstrated by independent benchmarks. Briefly, Harmony first
uses principal component analysis to project cells into a latent space. It then iteratively performs k-means
clustering and ridge regression to identify robust clusters that are not confounded by artifacts. Here, we propose
two aims to add new functionality to Harmony to eliminate some of the remaining bottlenecks.
In many use cases, a researcher will want to integrate their own data with a subset of an atlas, such as datasets
containing the same tissue type. To speed up this process, we will leverage our pre-calculated global integration
to allow for fast comparisons. This will be achieved by building a tree structure where nodes represent cell types
at various levels of granularity. New cells are then projected into the same latent space, and by traversing the
tree, we can quickly identify which existing cell types they most closely resemble. With cell atlases containing
millions of cells, downloading and storing the data can become an issue. One way to overcome this challenge is
to perform computations where the data resides, rather than transferring the data first. As previously mentioned,
Harmony relies on three classic algorithms (PCA, k-means, and sparse regression), all of which can be executed
in a distributed manner. In this context, we assume different parts of the data will reside on distinct servers, and
Distributed Harmony will require only summary statistics to be transferred between servers.
We envision that the proposed methods can be deployed in collaboration with organizations maintaining cell
atlases. Additionally, the distributed algorithms and infrastructure we develop will be valuable for many other
applications in computational genomics, e.g. population genetics and microbiome research.

Public health relevance
Project Narrative To develop new versions of Symphony and Harmony to allow for dynamic reference mapping and distributed batch integration of single cell RNAseq data. By using a precomputed hierarchical index, new cells can be rapidly compared to a reference, and we can find the best matches for fast integration. We will also develop distributed Harmony which will not need all of the data to be downloaded to a single machine and by carrying out computations where the data is residing only requires summary statistics to be transferred between servers.